Gene Therapy for Succinic Semialdehyde Dehydrogenase Deficiency (SSADHD)

Project summary/abstract (30 lines)
Succinic Semialdehyde Dehydrogenase Deficiency (SSADHD) is a rare genetic metabolic disorder caused by
ALDH5A1 mutations. ALDH5A1 encodes SSADH essential for the catabolism of the inhibitory neurotransmitter
γ-aminobutyric acid (GABA). In SSADHD, pathologic accumulation of GABA and metabolite γ-hydroxybutyrate
(GHB) leads to broad spectrum encephalopathy. Paradoxically, despite heightened ambient GABA, patients
with SSADHD are susceptible to seizures and sudden unexpected death in epilepsy (SUDEP), highlighting the
significance of compensatory down-regulation of GABA receptors over pathologic GABA build-up. A major
unmet medical need for SSADHD is treatment directly addressing the underlying enzyme deficiency such as
gene restoration therapy. Proof-of-concept aldh5a1 restoration via adeno-associated virus (AAV) increased
survival of SSADH-deficient aldh5a1lox-STOP mice and reversed SSADHD-relevant phenotypes. Furthermore,
restoration of ~15% SSADH in relevant cell types is sufficient for enhanced survival. An AAV encompassing a
human ALDH5A1 full-length native promoter (FLnP) driving a functional recombinant ALDH5A1 gene is a
potential cure for patients with SSADHD. However, it is unclear whether AAV-FLnP-ALDH5A1 drives sufficient
functional SSADH expressions in patient cells, and whether systemic AAV delivery (requiring high AAV dose)
might lead to therapeutically meaningful brain target engagement. We propose to use patient induced
pluripotent stem cells (iPSC)-derived neurons and the SSADH-deficient aldh5a1lox-STOP mouse model to study
efficacy and safety of this novel AAV-FLnP-ALDH5A1 construct. R61 Aim 1: Measure SSADH restoration,
cultured medium GHB content, and functional properties of patient iPSC-derived neurons. Go-no-go: At least
50% SSADH restored, functional phenotype returned to control. R61 Aim 2: Measure SSADH restoration in
brain tissues, GABA receptors, GHB content in blood, electrographic seizures, and survival in SSADH-deficient
aldh5a1lox-STOP mice. Go-no-go: GHB reduced to <15µM, reduced seizures and two-fold lifespan extension.
R33 Aim 3: Utilize dose de-escalation to determine minimal AAV-FLnP-ALDH5A1 (in AAV9 serotype)
threshold for therapeutic effects, and long-term toxicity in SSADH-deficient mice. The project goal is two-fold:
1) Provision of molecular insights into whether AAV-FLnP-ALDH5A1 is a viable clinical candidate for
SSADH gene therapy. The proposed study provides necessary insights into whether this novel AAV
construct is sufficient for phenotypic reversal in patient-derived iPSC, and whether this gene expression
cassette FLnP-ALDH5A1 is effective in various cell types including excitatory and inhibitory neurons.
2) Establishment of practical AAV dosage for therapeutic SSADH gene restoration therapy. The
proposed study provides necessary insights into minimal threshold for systemic delivery of translatable AAV
serotype leading to brain-wide coverage and associated phenotypic reversal in SSADH-deficient mice,
advancing future translational and clinical development of SSADH gene therapy.

Public health relevance
Project narrative (3 sentences) SSADHD is a rare inborn metabolic disorder characterized by broad spectrum encephalopathy including developmental delay, intellectual disability, seizures and a risk of sudden unexpected death in epilepsy (SUDEP). SSADH-targeted gene restoration therapy is a potential cure for this debilitating disorder, but a viable vector candidate capable of driving functionally sufficient SSADH in human neurons leading to demonstrable phenotypic curable outcome is currently unavailable. Our proposal aims to develop a novel adeno-associated virus (AAV) vector with human SSADH promoter driving functional human SSADH expressions in patient stem cell-derived neurons and determine whether systemic delivery of such clinically translatable AAV vector in SSADH-deficient mice results in safe and effective SSADH restoration with appreciable phenotypic rescue, advancing the preclinical development of SSADH gene therapy for SSADHD patients.